Project 2: Innate immune responses triggered by M. tuberculosis phagosomal perforation

Project Summary/Abstract (Project 2, Cox)
Tuberculosis (TB), caused by infection with Mycobacterium tuberculosis, remains a major cause of human
morbidity and mortality, particularly in the developing world. The spread of antibiotic resistant strains of M.
tuberculosis has increased the urgency to develop new vaccines with greater efficacy than Bacille Calmette-
Guerin (BCG), which is ineffective to prevent pulmonary infection in adults, by far the most common form of
TB. The ESX-1 secretion system of Mycobacterium tuberculosis is a key virulence determinant that is required
for intracellular growth and for eliciting distinct innate immune responses, autophagy and type I interferon (IFN)
during infection. BCG is extremely similar to M. tuberculosis but it lacks ESX-1 and thus cannot trigger these
powerful innate immune pathways. The overarching goal of this project is to identify the M. tuberculosis factors
that specifically activate these responses, and use this to create BCG strains that engage these pathways
during vaccination. In Aim 1, we investigate ESX-1 secreted substrates that are required for perforating
phagosomal membranes in collaboration with Project 1, and use a new system to express these factors in
BCG to restore perforation but without the rest of the ESX-1 secretion system. In Aim 2, we explore two
hypotheses for how M. tuberculosis limits targeting to autophagy, a powerful anti-bacterial host defense
mechanism. In Aim 3, we will utilize our existing knowledge, as well as information from Aims 1 and 2, to
engineer BCG strains to specifically test the role of autophagy and type I IFN in promoting immunity. Moreover,
we will collaborate with Projects 1, 3, 4, and Core B, to compare and combine our recombinant BCG strategy
with STING-targeted adjuvants (Project 4) and bacterial metabolites (Project 1) to identify synergies between
these approaches, and to test their efficacy in novel models of vaccination (Projects 3 and 4). Thus, these
studies will not only provide deeper mechanistic understanding of how autophagy and anti-viral signaling are
activated, but may lead directly to the creation of new TB vaccines.

Public health relevance
Project Narrative (Project 2, Cox) We have shown that M. tuberculosis initiates both anti-bacterial autophagy responses and pro-bacterial type I interferon responses of host macrophages, an effect that likely requires phagosome perforation mediated by the bacterium. We seek to understand the mechanism by which M. tuberculosis damages host membranes yet minimizes delivery of the bacterium to the autophagy pathway. In this proposal, we seek to use this information to test the effects of increased autophagy and interferon on eliciting protective immunity in order to create an effective vaccine.